Targeting myeloid suppression to enhance anti-tumor immunity in breast cancer

Project Summary
Myeloid immune suppression, driven by macrophages and monocytes, is a known mechanism of intrinsic
resistance to immune checkpoint inhibition (ICI), which has provided significant and durable responses in
patients with advanced cancers, but not in most breast cancer patients. Our laboratory has been instrumental in
demonstrating that targeting myeloid immunosuppression via decreasing the function of immature myeloid
derived suppressor cells (MDSCs) is a novel and important strategy to sensitize the tumor
microenvironment (TME) and improve the response to ICIs in breast cancer. We published two preclinical
studies demonstrating that entinostat, a class I histone deacetylase inhibitor, decreased MDSC suppression of
T cells; furthermore, combining entinostat with the ICIs nivolumab and ipilimumab improved survival in murine
models of breast cancer. This provided a strong rationale for our Phase I clinical trial (NCI-9844) where we
determined the recommended phase 2 dose (RP2D) for this treatment, given to patients with advanced solid
tumors, including 10/33 with breast cancer, as a two-week pre-treatment with entinostat, followed by the
combination of entinostat + nivolumab + ipilimumab. Furthermore, an overall response rate (ORR) of 30% was
observed in an expansion cohort of 20 patients with advanced breast cancer, who received the RP2D.
Nevertheless, we have yet to understand how entinostat decreases myeloid suppression to achieve TME
sensitization that leads to this striking response to ICIs.
Preliminary data in preclinical models demonstrate that entinostat 1) decreases suppressive function of intra-
tumoral MDSCs; 2) decreases the activation of the STAT3-NFkB-AP-1 signaling axis; and 3) alters the
phenotype and/or infiltration within the TME of other myeloid cells, including tumor associated macrophages
(TAMs), and dendritic cells (DCs). Preliminary evaluation of patient samples from our clinical trial confirms these
findings. Thus, we hypothesize that entinostat decreases MDSC immunosuppression and shifts the
phenotype and function of TAMs, and DCs to collectively sensitize the TME to promote an enhanced
response to ICIs. The Specific Aims are: 1) to determine the effects of entinostat on the STAT3-NFB-AP-1
axis decreases MDSC-mediated T cell suppression; and 2) to determine the cellular basis of entinostat-induced
sensitization of the TME and how it mediates the anti-tumor response to ICIs. Our unique bidirectional approach
combining preclinical studies, e.g., mouse models and mathematical modeling, with hypothesis-driven
correlative investigations in patients, and vice versa, strengthens our ability to uncover the molecular and TME
mechanisms driving clinical responses. These studies will reveal if changes in myeloid suppression and/or tumor-
immune dynamics inform response to therapy or survival, while identification of new biomarkers may improve
patient stratification for future trials.

Public health relevance
Project Narrative For many patients with cancer, immune checkpoint inhibitors (ICIs) have transformed the course of their diseases; however, only a small subset of patients with breast cancer have benefited from this therapy, in part because of high levels of immunosuppression imposed by myeloid cells in the patient’s tumor. This proposal will determine how treatment with entinostat, an epigenetic modulating drug and inhibitor of histone deacetylase, improves the response to ICIs in metastatic breast cancer via its effects on myeloid immunosuppression and on other suppressive immune cells, tested in mouse models and in samples from breast cancer patients in our clinical trial NCI-9844. The study will reveal new biomarkers and targets for therapy, assisted by a mathematical model that will decipher the complex and collective mechanisms of altered suppression, and predict tumor response to therapy.